Structural basis of ER-mitochondria membrane contacts and neuronal health

Project Summary/Abstract
The long-term objective of this research program is to understand the molecular mechanisms of Ca2+ signaling
in neurons intimately linked to neural health and function. In this project, our particular emphasis is on uncovering
the structural and molecular foundations underlying Ca2+ signaling at specialized membrane contact sites
between the endoplasmic reticulum (ER) and mitochondria. These ER-mitochondria contacts (ERMCs) are
hotspots for Ca2+-transport from the ER, the cell’s major Ca2+ storage organelle, to mitochondria. Inositol 1,4 5-
trisphosphate receptors (IP3Rs) are the most widely expressed Ca2+ release channels residing in the ER
membranes and are essential components of ERMCs, participating in both membrane tethering and as a Ca2+
transport system that is activated by IP3 to liberate Ca2+ sequestered in ER stores. IP3Rs serve as scaffolds at
these ERMCs, where they interact with other proteins and form multiprotein complexes, responsible for the
precise regulation of Ca2+ signaling in response to various extracellular and intracellular signals. This regulation
is crucial for many cellular processes, including cell signaling, metabolism, and apoptosis. Emerging evidence
suggests that functional IP3Rs cluster within ER membranes, and this spatial organization ensures that Ca2+
release is appropriately coordinated and tailored to specific cellular needs. Dysregulation of IP3Rs or loss of
IP3Rs by knockout have been reported to reduce the ERMCs that leads to pathological conditions by either an
exaggerated cell death, as in neurodegenerative diseases, or escape from cell death as in some types of cancer.
Despite the rapid progress carried out in recent years, the structural basis and molecular mechanisms underlying
protein-protein interactions at ER-mitochondrial membrane contacts remain largely obscure. The lack of any
satisfactory explanation for how IP3Rs are assembled into clusters and communicate with other organelles
highlights the urgent need to structurally characterize the subcellular geography of IP3Rs and their interactions
with mitochondria. In this project to address this long-standing conundrum, we will utilize cutting-edge cryogenic
electron tomography (cryoET) to study frozen-hydrated IP3R complexes within ER-mitochondrial membrane
junctions isolated from mouse brain (aim 1) and in situ within mammalian cells expressing recombinant IP3Rs as
well as in native neurons cultured on EM grids (aim 2). To accomplish these studies, we endeavor to develop an
experimental workflow for in situ cryoET analysis that will have broad applicability to studies of other subcellular
macromolecular complexes. The proposed work is highly important as it will shed light on the complex network
of IP3R molecular interactions within neurons, with implications for a wide range of biological processes and
diseases. Anticipated structural and molecular insights will serve as a platform for the development of potential
therapeutic approaches to restore normal organelle membrane contacts to improve neuronal functions.

Public health relevance
Project Narrative Impaired communication between cellular organelles has been claimed as an important disease mechanism in many neurological disorders, including Alzheimer’s disease, Parkinson’s disease, Huntington’s disease, amyotrophic lateral sclerosis, and other. The mechanisms by which alterations at organelle membrane contacts contribute to human neurodegenerative disorders are poorly understood that is largely due to the lack of architecture of multiprotein complexes that physically tether organelle membranes and maintain proper calcium hemostasis essential for neuronal function. The proposed studies will unravel the structural basis of protein- protein interactions involved in establishing and maintaining these membrane contacts, and this knowledge is essential for developing therapeutic inventions for neurodegenerative diseases.